COVID-19 Mitigation Efforts and Disparities in Access to Routine Preventive Care and Chronic Disease Management

PROJECT SUMMARY
As a result of mitigation policy and behavioral changes, the COVID-19 pandemic significantly reduced access
to primary care, which is likely to have lasting effects on chronic disease management and health outcomes,
particularly for medically and socially vulnerable populations with existing chronic conditions. Newly available
longitudinal individual-level data allows us to rigorously examine these effects for the first time.
Although there is a large and growing literature quantifying disparities in outcomes related to COVID-19,
relatively less is known about how the pandemic has affected access to primary and preventive care as well as
associated health outcomes among medically and socially vulnerable populations. Understanding how the
pandemic affected the utilization of preventive health care and management of chronic conditions, such as
diabetes mellitus (DM) and hypertension (HTN), as well as the downstream outcomes, is critical to addressing
resultant health disparities and mitigating the impact of future disruptions to the healthcare system and
advancing interventions and policies to reduce health disparities
We will leverage this newly available and timely data to examine changes in receipt of healthcare during the
pandemic. Our data will include commercial health insurance claims in addition to a unique dataset containing
billing data for a large, urban safety-net county health system serving a low-income, largely minority patient
population. Within those populations, we will include a special focus examining individuals with DM or HTN.
Using a mixed-methods design, we will examine changes in health care utilization and the predictors of
disruptions over time. To more comprehensively understand contextual influences related to disruptions in
care, we will obtain complementary qualitative data through interviews with patients, providers and clinic staff,
and health systems leaders from the second largest municipal health system in the United States that will
explore the drivers of underutilization of primary and preventive care during and after the pandemic. Our
specific aims are to: (1) quantify the impact of the pandemic on racial/ethnic disparities in receipt of appropriate
primary care, chronic disease management, and downstream health outcomes; (2) compare the differential
effect of pandemic mitigation efforts between a commercially insured population and a safety net population;
and (3) contextualize the secondary health effects of the pandemic using qualitative interviews with health
systems stakeholders.
Using established and novel data sets, supplemented by qualitative interviews we will be able to shed light on
the changes in patterns of care management both during and after the pandemic for medically and socially
vulnerable patients. Such information is crucial to determining how we should direct health care resources
during national crises. However, these results are equally important in a post-pandemic landscape, in which
the way patients seek care and health systems offer care is permanently altered.

Public health relevance
PROJECT NARRATIVE COVID-19 related mitigation efforts and increased social distancing have impeded access to primary care and chronic disease management, especially for medically and socially vulnerable populations. In this study, we will use a mixed-methods approach combining established and novel data sets with qualitative interviews to understand the short- to medium-term secondary health impact of the COVID-19 pandemic. The results of our study will provide crucial information to help determine how we should direct health care resources during national crises and how to rebuild an equitable health system in the post-pandemic period.